Examining Glycine Receptor's Intracellular Domain by Crosslinking-Mass Spectrometry

Project Summary. While high-resolution structural data are available for members of the pentameric
ligand-gated ion channel (pLGIC) superfamily in membrane-mimetic environments, the structure of
the intracellular domain (ICD) of these receptors in lipid bilayers remains unresolved. Our aims are to
conduct crosslinking mass spectrometric studies (CXMS) to complement current methods and
characterize the structure of full-length a1 glycine receptors (GlyRs) in reconstituted bilayers different
allosteric states, with a particular focus on the ICD. Specific Aim 1 will use CXMS to interrogate the
protein structure of the ICD around single sites of attachment of a variable-length photoactivatable
protein-protein crosslinkers distributed over the full length of the ICD as a function of GlyR allostery.
Specific Aim 2 will use CXMS to examine lipid-protein interactions as a function of allostery using lipid
crosslinkers with their respective photoactivatable moieties at different depths of the bilayer, with a
particular focus on the close associations of the ICD with the lipid bilayer. Together, the CXMS approaches
used in each Aim will provide insight into the structure of this previously unresolved domain and
complement high resolution studies conducted in membrane-mimetic environments.

Public health relevance
Project Narrative. The proposed research is relevant to public health because knowledge of how ionotropic receptors function at a molecular level is necessary to understand their allosteric modulation and their interactions with anesthetics, drugs and therapeutics. In particular, the proposed research is relevant to NIGMS’s mission because it will transform our understanding and ability to modulate neuronal communication.